New Vulnerabilities in MYC-Driven Breast Cancer

Triple-negative breast cancer (TNBC) is an aggressive subtype of breast cancer with more than
200,000 new diagnoses each year. The oncogene Myc is a common driver of TNBC. However, despite
important research into the biologic and molecular functions of Myc, no tractable therapies have emerged to
inhibit this oncogenic transcription factor. TNBC and other Myc-driven cancers remain recalcitrant to current
targeted therapies, underlining the urgent need to identify new vulnerabilities in these malignancies.
In addition to promoting tumorigenesis, oncogenes such as Myc also produce unique stresses in
cancer cells, collectively termed oncogenic stress. Using parallel whole-genome RNAi screens, we discovered
that Myc imposes a new type of oncogenic stress on TNBCs that we term RNA splicing stress, or RSS
(Kessler, Science 2012; Hsu, Nature 2015). In many cancer types, Myc (or other oncogenic insults) globally
amplifies transcription leading to increased pre-mRNA burden on the spliceosome. Consequently, Myc-driven
TNBCs are exquisitely sensitive to modest perturbations in the spliceosome (by enhancing RSS). Importantly,
pharmacologic or genetic inhibitors of the spliceosome impair primary and metastatic progression of TNBC and
are well tolerated in animal pre-clinical models. While spliceosome inhibitors have entered clinical trials, the
mechanisms by which RSS and spliceosome inhibitors selectively kill cancer cells are unknown. Herein, we
propose to discover the pathway(s) sensing and responding to RNA splicing stress and to delineate the
mechanisms by which RSS triggers cancer cell death.
Aim 1: Delineate the dsRNA-sensing pathways (DSP’s) stimulated by RSS in Myc+ TNBCs in vivo. Our
preliminary data suggest that RSS induces TNBC apoptosis by triggering innate immune pathways that detect
and respond to dsRNAs. By leveraging a TNBC PDX cohort with new genetic and proteomic platforms, we will
determine how DSP’s and other stress response pathways are activated in response to spliceosome inhibition.
Aim 2: Discover how RSS triggers dsRNA-sensing pathways in TNBCs. Many viral pathogens encode
dsRNA genomes that are detected by dsRNA-sensors of the innate immune system. Our studies indicate
RSS leads to cytoplasmic accumulation of intron-retained mRNAs, a potential source of dsRNAs. Using new
sequencing and single-molecule microscopy methods, we will study the mechanisms by which RSS shapes
the secondary structure and subcellular localization of TNBC transcriptomes and stimulates dsRNA-sensors.
Aim 3: Delineate how DSPs and other stress response pathways govern TNBC response to
spliceosome inhibitors. We hypothesize that there is a coordinated cellular response to RSS that parallels
well-studied homeostatic stress responses like the unfolded protein response. By leveraging forward genetics
and identifying new regulators of RSS, we propose to unveil a genetic framework for this novel type of cellular
stress and provide new therapeutic inroads that exploit this cancer vulnerability.

Public health relevance
Project Narrative Our proposal aims to develop new strategies to combat a common and aggressive subtype of human breast cancer (triple-negative breast cancer, or TNBC). We recently discovered that Myc+ TNBC and other Myc- driven malignancies harbor a new vulnerability termed RNA splicing stress (RSS), though the underlying mechanism(s) of RSS are unclear. We propose to elucidate how RSS impairs TNBC survival and progression, to discover the stress response pathways that respond to this new form of oncogenic stress, and to develop therapeutic hypotheses that leverage this vulnerability in animal models of TNBC.